Structure and Functional Imaging of Age-Related Changes in Working Memory

DESCRIPTION (provided by applicant): This project proposes to use structural and functional neuroimaging methods to better understand how the brain changes in healthy aging, and the consequences of those changes on cognitive function. It examines age-related changes in working memory ability - a fundamental capacity that underlies many complex cognitive behaviors, and that declines with age. The central hypothesis of this study is that working memory ability arises from coherent neural oscillatory activity in a network of brain regions, and that age-related declines in working memory ability reflect the breakdown of coherent neural activity in this network due to age-related changes in white matter structure. To test this hypothesis, high temporal resolution methods of electro- and magnetoencephalography (EEC and MEG) will be integrated with the high spatial resolution method of functional magnetic resonance imaging (MRI) to characterize the dynamic spatiotemporal patterns of brain activity that underlie working memory ability in young adults, and to determine how healthy aging affects these patterns. Diffusion tensor imaging (DTI) will be used to assess white matter microstructural integrity, and age-related reductions in coherent activity between distributed neural regions will be related to age-related reductions in white matter integrity. It is hypothesized that age-related changes in frontal white matter disrupts the coherent activity in frontal-parietal networks necessary for working memory task performance, and that the reduction in frontal white matter integrity contributes to age-related reductions in regional frontal cortical thickness. To achieve these research goals, the candidate, who has a strong background in MEG and EEC research, seeks training through formal coursework and interaction with her sponsors in structural and functional MRI acquisition and analyses, multimodal integration of MEG/EEG and MRI data, cortical reconstruction, parcellation, and quantification, and DTI acquisition and analyses. Her sponsors, leaders in the field of neuroimaging and multimodal analyses, and the supportive and resource- rich environment of UCSD, will ensure the candidate's mastery of these new techniques. Relevance: This project will further understanding of the structural and functional changes in the brain that occur as part of normal aging, and that underlie age-related changes in cognitive ability. This knowledge will provide a basis for better understanding of pathological brain changes that occur in age-related disorders.